International Hearing Aid Conference (IHCON) 2024

Abstract
The 2024, 2026, and 2028 meetings of the International Hearing Aid Research
Conference (IHCON) will be the 17th, 18th, and 19th times that this biennial research
conference is held. The purpose of IHCON has been and will continue to be to advance
knowledge and facilitate progress in research and development related to the treatment
of hearing impairment with hearing aids, through the exchange of current research findings
and technical advancements. A hallmark of past IHCON meetings has been their ability to
draw together the disciplines and specialties essential to the advancement of hearing-aid
research taking place within the US and abroad. A primary goal of each IHCON meeting
is to build upon the strengths of the previous meetings and to showcase the current and
emerging multidisciplinary research areas that will best meet the needs of the hearing-aid
community in the coming years, while also increasing participation from underrepresented
groups (URGs). New in 2024, a Diversity, Equity, and Inclusion (DEI) Chair has been
appointed to facilitate the recruitment of participants from URGs, including Blacks,
Hispanics, Native Americans, and women. The International Hearing Aid Seminar (IHAS)
will continue to be held immediately before the main IHCON meeting, which will encourage,
train, and mentor students entering the hearing-aid research and development field.

Public health relevance
Narrative Approximately 15% of American adults aged 18 and over (38 million people) report some trouble hearing. Of these, about 29 million U.S. adults could benefit from using hearing aids. The 2024, 2026, and 2028 meetings of the International Hearing Aid Research Conference (IHCON) will advance knowledge and facilitate progress in research and development related to the treatment of hearing impairment with hearing aids, through the exchange of current research findings and technical advancements.